Community Engagement Core

SUMMARY: COMMUNITY ENGAGEMENT CORE
The CEC serves as the information and communications nexus for the GC-CPEH. Our overall goal is to assist
the communities we serve to achieve optimal environmental health, equity, and justice through a Community-
Based Participatory Research (CBPR) approach to research that equitably involves community partners in all
aspects of the research process. Our Vision is to foster healthy communities by increasing communication and
building collaborative relationships to implement research and programming responsive to community needs;
develop, adapt, and share innovative strategies for engagement; and improve use of scientific findings to inform
environmental health and health policy decisions. Specific Aims to achieve this Vision are: Specific Aim 1:
Engage community partners through multi-modal communication strategies that identify community needs and
inform Center directions and research and establish avenues for disseminating relevant environmental health
sciences (EHS) to collaborators (research to action and policy). Specific Aim 2: Advance the field of community
engagement and environmental health communication through innovative engagement strategies and
mechanisms that can be adopted as best practices. Specific Aim 3: Translate and disseminate EHS to increase
environmental public health understanding and enhance capacity of individuals and organizations to make
informed environmental health and policy decisions. Activities thus focus on multi-modal communications,
translating and disseminating EHS for our communities, rigorously evaluating program effectiveness, and
sharing best practices. CEC collaborators include Center leaders and members and targeted audiences
comprising community members including Veterans, and those engaged in EHS policy- and decision making.
We seek to increase diversity, inclusion, and equity throughout the Center's spectrum of work, guided by our
Plan to Enhance Diverse Perspectives (PEDP). The CEC uses multiple strategies to reach diverse partners
and audiences. SCI Café (where Science and Communities Interact) provides a venue for research translation
through informal dialogues among scientists and community members. EJ Encuentros, gatherings of
community members and investigators for encounter and discovery, provide forums for discussion to identify
emerging community environmental health issues that have led to Center research responsive to community
needs. A vital Community Advisory Board (CAB) informs Center science and provides a mechanism for
communication between and among our investigators and our extensive network of community partners.